IL-36 cytokines and gut immunity

Abstract
Crohn’s disease and ulcerative colitis, the two most common forms of inflammatory bowel disease (IBD), affect
approximately 1.5 million people in the United States. The etiology of IBD remains unclear, however dysregulated
innate and adaptive immune responses directed towards the microbiota are believed to underlie disease
pathogenesis. Currently biologic therapies targeting pro-inflammatory cytokines such as TNF and IL-12/23 have
shown great promise. However, much remains to be understood regarding the immune cells and factors that
contribute to IBD and how they can be controlled to improve human health. Our recent work, funded through
2018, which this application seeks to build upon, has unraveled important and complex contributions of the IL-
36/IL-36 receptor (IL-36R) axis in the regulation of innate and adaptive mucosal immune responses and intestinal
inflammation. We were the first to report that IL-36 ligands are expressed during acute and chronic experimental
colitis in mice and during human IBD. We have shown that IL-36 ligands, particularly IL-36g, are secreted by
inflammatory macrophages in response to intestinal barrier damage in mice. The biological consequences of
signaling through IL-36R during acute intestinal damage, as might be expected of an IL-1-related cytokine axis,
include enhanced inflammation. Strikingly, we observed that IL-36R signaling is also required during the
resolution phase of acute colonic injury for optimal neutrophil recruitment and IL-23/IL-22 expression. These
results led us to conclude that the IL-36/IL-36R axis regulates not only immune cell recruitment and inflammation,
but also protective repair processes that are linked to IL-22 and anti-microbial peptides. Thus, we speculate that
inflammation and barrier protection are intimately intertwined. Beyond innate immune responses, signaling
through IL-36R also has potent effects on CD4+ T cells. Our published work has demonstrated that IL-36 ligands
potently inhibit the induced regulatory T cell (iTreg) pathway, while concomitantly augmenting effector Th
responses. The in vivo relevance of these findings is evidenced by our studies showing reduced severity of Th
cell-dependent oxazolone colitis in mice deficient in IL-36R or IL-36g. Collectively, our findings highlight context-
dependent pathogenic and protective contributions of the IL-36/IL-36R pathway in the intestine. Our new
preliminary data demonstrate that: 1) IL-36g is not induced during acute barrier damage in germ-free mice and
can be induced in vitro by bacterial ligands; 2) The composition of the microbiota is altered in IL-36R-deficient
mice both in the steady-state and following acute barrier damage; 3) IL-36R expression by T cells and dendritic
cells is involved in augmenting inflammatory signaling; and 4) Inflammatory cytokines can be inhibited in specific
cells in the intestine using siRNA-loaded nanoparticles while simultaneously delivering pro-restitutive factors
such as IL-22. These data set the stage for further investigation into this exciting and important area of research.

Public health relevance
Project Narrative The present resubmission application (A1) will focus on defining how the IL-36/IL-36R axis influences innate and adaptive inflammatory signaling in the intestine using mouse models of colitis. The proposal will test the novel hypothesis IL-36 ligands are critical regulators of the microbiota, T cell and DC activation, yet also play a role in mediating epithelial barrier protection and restitution via IL-22. Specific targeting of IL-36 ligands in the colon using nanoparticles carrying siRNA will allow for the assessment of whether manipulation of the IL- 36/IL-36R axis during active colitis may have potential therapeutic value for treating human with intestinal diseases driven by pro-inflammatory immune responses such as inflammatory bowel disease.